Equipment for Discovering and Manipulating Macromolecular Conformational Ensembles

The abstract of the funded parent award is contained in the 2 page Research Strategy attachment
required under NOT-GM-24-021. (See Research Strategy Section).

Public health relevance
See Research Strategy Section for Project Narrative.